Administrative Core

Administrative Core: Project Summary
The overarching goal of the UPSTREAM Research Center Administrative Core is to provide the administrative support necessary to direct research activities through a cohesive, integrated, and efficient Center that will serve as a critical hub and resource for participating institutions, community partners, and the national network of persistent poverty centers. The Administrative Core will bring together a coalition with unparalleled resources and reach, and coordinate activities across multiple institutional and community partners: the Comprehensive Cancer Centers of Stanford University, the University of California, San Francisco (UCSF) and the University of California, Davis (UCD); state and local governments; and community-based organizations. The Administrative Core will help build research capacity in areas of persistent poverty, support community-engaged research and develop capacity for implementing multi-level and multi-factorial cancer prevention and control interventions that include basic income interventions. As the hub for the management and coordination of all Center activities, the Administrative Core will create synergy within the Center and across the national network of persistent poverty centers. We will maximize efficiency, cost-effectiveness, and productivity by centralizing common administrative and operational resources. The goals of the center and the means of achieving those goals will be guided by a Regional Coalition of Community Partners who will play an active role in the functioning of the administrative Core and the overall center. Dr. Melissa Bondy, Professor and Chair of the Department of Epidemiology and Population Health at Stanford University and Associate Director for Population Health at the Stanford Cancer Institute (SCI) will lead the Administrative Core, supported by Dr. David Rehkopf (Stanford), Dr. David Grusky (Stanford), Dr. Robert A. Hiatt (UCSF), and Dr. Luis G. Carvajal-Carmona (UCD), and Project and Core leaders, and the regional coalition on a Center Executive Committee (EC). The Administrative Core will convene weekly meetings, monthly full meetings, monthly Executive Committee meetings, and an annual retreat to foster collaboration and synergy. Day-to-day operations of the Administrative Core will be overseen by a dedicated Center Manager. The Administrative Core has the following Specific Aims: 1) Provide administrative leadership and integration of Projects and Cores across the proposed Center 2) Convene internal and external advisory board meetings and facilitate meaningful interactions between advisory boards, Center members, the regional coalition of community partners and other persistent poverty centers. 3) Develop a research workforce. 4) Build research capacity in persistent poverty areas and provide infrastructure for collaborative studies with community partners. 5) Establish practices to monitor Project productivity and assess use of Core resources. 6) Coordinate and implement broad results dissemination.